Omics Data Generation Center (ODGC) for the Acute to Chronic Pain Signatures (A2CPS) Program

Omics Data Generation Center (ODGC) for the Acute to Chronic Pain Signatures (A2CPS)
Program OVERALL PROJECT SUMMARY Chronic pain is a major health concern and one of the
most common reasons adults seek medical care. It is associated with substantial morbidity linked
to reduced quality of life, restricted mobility, depression, and opioid dependence. The biological
mechanisms that prevent the resolution of acute pain after the initial insult and drive the transition
from acute to chronic pain are poorly understood. The lack of rigorously validated biomarkers to
predict which patients are more susceptible to the transition from acute to chronic pain states is
thus a major gap hindering the development and implementation of population-wide and
individualized preventive pain interventions. In the A2CPS Consortium, the Clinical Centers will
recruit and collect clinical data and biofluid samples from two longitudinal cohorts of 1800
subjects each. Biofluid samples will be collected 0, 3, and 6 months after an acute pain episode,
consisting of a specific surgical procedure or a specific musculoskeletal trauma. These samples
will be used to generate multi-omic data to validate 40 primary outcome biomarkers indicating
susceptibility or resilience to development of chronic pain, as well as to identify new candidate
biomarkers. For the proposed A2CPS Omics Data Generation Center (ODGC), Aim 1, which will
be executed in Year 1, will involve close collaboration with other components of the A2CPS
Consortium to establish the final study design and protocols. All of the A2CPS Program
investigators will work together to establish the 40 primary outcome biomarkers. The ODGC and
Clinical Center investigators will jointly decide on the specific sample type(s) and
collection/processing/storage methods. The ODGC and Data integration Resource Center/Data
Coordination Component (DIRC/DCC) investigators will establish Metadata and Data Standards
and a workflow for submission of metadata and raw data to the DCC. The Administrative Core of
the ODGC will establish a LIMS for sample and data tracking and recording of metadata. The
ODGC will work closely with the DIRC/Data Integration and Analysis Component (DIAC) to
establish data analysis pipelines. ODGC investigators also anticipate participating in integrative
analyses with the DIRC/DIAC aimed at developing pain signatures comprised of multiple
biomarker types (including molecular, clinical, psychosocial, and/or imaging biomarkers)
indicating susceptibility/resilience to chronic pain, which can be used to develop personalized
strategies for prevention and treatment of chronic pain. Aims 2 and 3 will span Years 2-4, with
Aim 2 focused on data generation from the ~11,000 biofluid samples that will be collected by the
Clinical Centers. Aim 3 will encompass submission of metadata and data to the DIRC/DCC,
quality control of the data, and data analysis and interpretation. The primary goal of this project is
to establish the A2CPS Omics Data Generation Center to generate genetic variant, metabolomic,
lipidomic, proteomic, exRNA, transcriptome, and microbiome data from two pain cohorts to
validate 40 primary outcome biomarkers indicating susceptibility or resilience to development of
chronic pain and identify novel biosignatures predicting the transition from acute to chronic pain.

Public health relevance
OVERALL SPECIFIC AIMS Chronic pain is a major health concern and one of the most common reasons adults seek medical care [1]. It is associated with substantial morbidity linked to reduced quality of life, restricted mobility, depression, and opioid dependence [2]. In 2016, approximately 50 million U.S. adults were afflicted with chronic pain, with approximately 40% of them having high-impact chronic pain [2]. The societal cost of chronic pain is estimated at $560 billion annually in direct medical expenses, lost productivity, and disability programs [3]. The biological mechanisms that prevent the resolution of acute pain after the initial insult and drive the transition from acute to chronic pain are poorly understood [4,5]. The lack of rigorously validated biomarkers to predict which patients are more susceptible to the transition from acute to chronic pain states is thus a major gap hindering the development and implementation of population-wide and individualized preventive pain interventions [6]. The primary goal of this project is to establish the A2CPS Omics Data Generation Center (ODGC) to generate genomic variant, metabolomic, lipidomic, proteomic, exRNA, transcriptome, and microbiome data from two pain cohorts consisting of 1800 subjects each, with biofluid samples collected at 0, 3, and 6 months after an acute pain episode. These samples will be used to generate multi-omic data to validate 40 primary outcome biomarkers indicating susceptibility or resilience to development of chronic pain, as well as to identify new candidate biomarkers. Aim 1. Coordinate the ODGC Components and collaborate with the other A2CPS Program Centers to establish the final study design and protocols (Year 1). 1A. Work with all A2CPS Program investigators to select a panel of 40 candidate primary outcome biomarkers. 1B. Harmonize sample collection/processing/storage with the Clinical Centers and other ODGC Components. 1C. Collaborate with the ODGC Administrative Core and the Data Coordination Component (DCC) of the Data Integration and Resource Center (DIRC) to establish Data and Metadata Standards, and a workflow for submission of Data and Metadata to the DIRC. 1D. Collaborate with the ODGC Administrative Core to develop a Laboratory Information Management System (LIMS) to track sample and data flow and record technical metadata. 1E. Collaborate with the Data Integration and Analysis Component (DIAC) of the DIRC to establish data analysis pipelines for the seven omics components. Aim 2. Generate genomic variant, metabolomic, lipidomic, proteomic, extracellular RNA, transcriptome, and microbiome data from two cohorts consisting of 1800 subjects each, with biofluid samples collected at 0, 3, and 6 months after an acute pain episode to enable validation of a pre-selected set of 40 primary outcome biomarkers for prediction of transition from acute to chronic pain, as well as discovery of new biomarkers (Years 2-4). 2A. The Administrative Core will coordinate ODGC components, integrating the ODGC personnel, expertise and infrastructure into a flexible architecture that is responsive to programmatic challenges and successes. 2B. The Genetic Variant Core will perform reproducible analysis of gene variants carried by the 3600 participants using the Illumina Infinium Global Screening Array. 2C. The Proteomics Component will perform targeted proteomic-peptidomic analyses. 2D. The Metabolomics Component will perform both untargeted and targeted metabolomics with liquid chromatography and mass spectrometry (LC-MS). 2E. The Lipidomics Component will generate lipidomics data with LC-MS using various acquisition modes. 2F. The Extracellular RNA Component will perform small RNAseq and qRT-PCR assays on exRNA samples. 2G. The Other Assays: Transcriptomics, Microbiome & Developing Technologies Component will perform reproducible analysis of peripheral blood mononuclear cells (PBMCs) for transcriptomics, stool for microbiome analysis, and adapt to include other developing technologies as directed by the A2CPS consortium, such as epigenomics and Superresolution microscopy of brain-derived extracellular vesicles. Aim 3. Coordinate with the A2CPS Data Integration and Resource Center (DIRC) to transmit data and metadata and perform data quality control and analysis (Years 2-4). 3A. Submit standardized metadata and raw data from Aim 2 to the DIRC. 3B. Collaborate with the DIRC DIAC on data analysis, particularly integration of multi-omics data with clinical and imaging data to discover new biomarkers of chronic pain susceptibility or resilience.